Evaluation of inflammation in the locus coeruleus during physical withdrawal symptoms and cognitive development in a rat model of neonatal opioid withdrawal syndrome (NOWS)

Abstract
In the past decade, opioid use disorders have significantly increased in pregnant women and women of
childbearing age. In parallel, we have seen a drastic rise in neonatal opioid withdrawal syndrome (NOWS).
Despite having well-defined, short-term phenotypic symptoms for NOWS, molecular effects and long-term
consequences are incomprehensible. This is of particular concern given that opioid exposure alone, as well as
withdrawal, can induce inflammation in the brain, and recent work has shown an increase in pro-inflammatory
cytokines and chemokines, which may be promoted by reactive glia as a result of in utero opioid exposure.
Moreover, cognitive functioning and memory deficits have been observed in preclinical models of in utero
opioid exposure, and intellectual impairments and increased attention disorders have been observed in clinical
populations previously diagnosed with NOWS. While much of the research has focused on inflammation and in
utero opioid exposure in brain regions associated with reward and cognition, less is known about the brain
regions associated with withdrawal symptoms in NOWS, and how this may relate to cognitive function later in
life. Understanding the pro-inflammatory effects of in utero opioid exposure and withdrawal may allow for novel
targets for the treatment of NOWS, and better understanding of long-term consequences. Therefore, by using
an established rat model of NOWS that has previously shown an upregulation of inflammatory markers due to
in utero opioid exposure, we will investigate inflammation in a withdrawal-associated brain region, the locus
coeruleus, and determine effects on behavioral indices of withdrawal and subsequent cognitive function. More
specifically, in a rat model of NOWS, we will utilize immunohistochemistry, qPCR, and multiplex assays to
evaluate inflammatory markers including reactive glial cells, toll-like receptor 4 expression, and levels of pro-
inflammatory cytokines and associated neuropeptides, and their respective associations with quantified
behavioral withdrawal symptoms. In addition, we will test the specific role of reactive glia on physical
withdrawal symptoms in the rat neonate by systemically administering the glia-inhibiting agent, minocycline.
We will assess the resultant cognitive function at PN21 and PN60, when rats are considered preadolescent
and early adulthood, respectively. We will test spatial learning and memory in heroin- or saline-exposed rat
pups who experienced precipitated withdrawal at PN10. Additional experiments will also include the use of
neonatal, systemic minocycline administration to mitigate cognitive deficits previously observed in preclinical
and clinical populations of NOWS. Together, these experiments will allow us to better understand the effects of
inflammation on physical withdrawal symptoms, as well as the relationship between physical withdrawal
symptoms and subsequent cognitive function, as a result of in utero opioid exposure and precipitated
withdrawal, thereby establishing novel targets for the treatment of NOWS and laying the foundation for future
studies evaluating its long-term consequences.

Public health relevance
Project Narrative Rates of neonatal opioid withdrawal syndrome (NOWS) have drastically increased in the past decade, with about 80 babies per day born with NOWS, and the combined associated medical and educational costs projected to be more than $400 million, annually. Recent evidence has suggested that inflammation is present as a result of in utero opioid exposure, and, while inflammation is present during periods of withdrawal in adult rodent models of heroin addiction, the molecular mechanisms of withdrawal in NOWS and long-term effects, such as those related to cognition, remain incomprehensible. Utilizing a rat model of NOWS, we will evaluate inflammation as it relates to physical withdrawal symptoms and subsequent cognitive function in associated brain regions to better understand this debilitating and costly disease.